Characterizing Dynamic Neural Indices of Sound Sensitivity in Autism

Project Summary/Abstract
Up to seventy percent of autistic individuals report challenging auditory sensory experiences despite
having normal hearing thresholds. These experiences include both increased and decreased sensitivities to
sounds, as well as difficulties attending to and ignoring sounds. Furthermore, these experiences are exacerbated
by stress and fatigue, indicating the role of arousal-related systems in mediating these sensitivities. Despite the
prevalence of these experiences, prior research has failed to identify consistent differences in neural activity in
brain regions responsible for auditory sensitivity, attention, and arousal, thus hindering the development of
effective treatments and sensitive measures.
Importantly, these brain regions compose a circuit that adjusts auditory sensitivity in response to the
environment, but no research has investigated whether the dynamics of this circuit are different in autism. We
will address this gap by measuring the integrity of the neural circuit through which arousal modulates auditory
perception and vice versa. We hypothesize that auditory difficulties in autism emerge from different dynamics of
the neural circuit that maintains auditory sensitivity, rather than unvarying increased or decreased activity in any
of these regions in isolation.
We test this hypothesis with a novel experimental approach. Participants will hear sounds of varying
intensity as we co-register electroencephalography (EEG) and pupil diameter (PD). Simultaneous measurement
of EEG and PD allows us to determine the extent to which individual brain responses reflect the influence of
exogenous factors, such as sound intensity, relative to endogenous factors such as arousal. We quantify the
strength of these associations using novel regression models developed for the analyses of time-varying
relationships at the level of single trials. These neurophysiological measures will be integrated with clinical
assessments of auditory sensitivity to understand relationships among circuit dynamics and auditory experience.
This research will generate important knowledge elucidating the mechanisms of auditory sensitivity in
autism. This knowledge will facilitate progress in the development of sensory-specific biomarkers and
interventions, which the field currently lacks. Finally, unlike prior research that has focused on mean differences
between groups, we aim to identify an explanatory mechanism for variability within individuals.

Public health relevance
Project Narrative This project focuses on the neural circuit that mediates sound sensitivity and its relationship with sensory sensitivity in individuals with autism. By Integrating pupil dilation with EEG, the study will investigate the extent to which frontal cortical activity and subcortical mechanisms mediate the balance of excitation and inhibition in the brain and how this balance is associated with cortical response to sound. This project holds promise for treatment development and selection and defining subgroups of autistic individuals based on mechanistically informed sensory biomarkers.